Engineering pluripotent stem cells to evade and promote immunity

PROJECT SUMMARY / ABSTRACT
Pluripotent stem cells hold great promise for regenerative medicine. Beyond their ability to restore normal
tissues, their potential can be expanded even further through engineering approaches to create new lineages
with therapeutic properties that are not normally made in vivo. In preliminary studies, we have created pluripotent
stem cell lines that 1) have been genomically edited such that they are able to cross human-mouse barriers; 2)
engineered these cells to carry a knockin insertion of a broadly neutralizing HIV antibody at the endogenous loci.
With these cells, we will develop strategies to differentiate human pluripotent stem cells into transplantable
pathogen-specific plasma cells. This process will involve iterative and recursive steps to engineer pluripotent
stem cell differentiation to downstream hematopoietic, B cell, and plasma cell lineages using single cell
transcriptional trajectories as guides. These targeted approaches will be complemented with unbiased genetic
and small molecule screens for new pathways that promote or inhibit specific steps in differentiation, and
additional single cell transcriptomic and epigenetic analyses to provide templates for cellular engineering.

Public health relevance
Project Narrative / Relevance For many pathogens, effective vaccines do not exist. The goal of this proposal is to generate stem cell-based therapies against such infectious pathogens.